Individual Differences Listening in Noise in Clinically Normal-hearing Adults

Project Summary
Young adults with normal audiometric thresholds vary widely in their ability to listen in everyday noisy
environments. Many perform as poorly in studies as their age-matched, hard-of-hearing counterparts [Kidd et
al. (2002). J. Assoc. Res. Otolaryn. 3, 107-119]. The variation challenges the conventional view of hearing
loss, which assumes the audiogram to be the gold standard for evaluating hearing; however, the causes of the
variation remain unclear. Now, new developments in our lab and others promise progress in understanding.
Measures of threshold fine structure have shown that wide individual variation in thresholds are missed by the
conventional audiogram [Lee & Long (2012). Hear. Res. 283, 24-32]. Individual differences in decision weights,
taken to reflect the reliance listeners place on different frequencies in psychophysical tasks, have been linked
to irregularities in cochlear micromechanics unique to individual ears [Lee et al. (2016), Adv. Exp. Med. Biol.
894:457-465]. Computational models have isolated a small number of factors that show promise in predicting
individual differences across diverse target-in-noise listening tasks [Lutfi et al. (2013), J. Acoust. Soc. Am.
134:2160-2170]. And, levels of noise exposure, once thought to present no risk of harm, have been shown to
produce irreversible loss of synaptic connections to hair cells and subsequent degeneration of afferents in
mice. The pathology is not detected by conventional audiometry, leading to speculation that it may be
widespread in the population, affecting listening in noise [Kujawa and Liberman (2009), J. Neurosci.
29(45):14077–14085]. Sparked by these developments, this proposal represents a new effort to understand
individual differences in the ability of young clinically normal-hearing adults to listen effectively in noise. It
differs fundamentally from past efforts in approach. The goal is to isolate the primary sources of variation and
model their effects by determining precisely how listeners differ in their use of information distinguishing targets
from noise. This is achieved by (1) formulating a general decision model relating the listener's trial-by-trial
judgments to this information, (2) estimating the parameters of this model by logistic regression of the trial-by-
trial data and (3) comparing the estimated values to those of a maximum-likelihood observer that yields best
performance for each task. The approach represents a significant advance over conventional methods that
infer underlying processes from measures of performance accuracy. Specific aims are to apply this approach
to (1) determine the relative contribution of peripheral and central processes and their interaction to individual
differences, (2) account for general patterns of listener behavior from `individual listening styles' and (3)
develop a low-parameter computational model for predicting individual differences across diverse listening
tasks. It is expected that the knowledge gained from these studies will inform efforts that seek to improve the
evaluation, classification and treatment of what is a debilitating problem for many, the challenge of listening in
everyday noise.

Public health relevance
Project Narrative This project addresses a fundamental problem of audiology – understanding why young, healthy individuals whose hearing is evaluated to be normal differ so dramatically in their ability to listen effectively in everyday noisy environments. The achievement of aims promises to expand our understanding of dysfunctional hearing to include central and peripheral factors known to limit effective listening in noise, but undiagnosed in conventional audiometric testing.